Investigating the Role of Epigenetic Changes in Early Development and Prevention of Cardiovascular Inflammation

PROJECT SUMMARY
Cardiovascular disease (CVD) kills one person every 37 seconds in the U.S. and those with type 2 diabetes
mellitus (T2DM) have a 2-fold higher mortality following a myocardial infarction. The principal cause of T2DM
morbidity and mortality is CVD. Genetic risk factors and biomarkers for T2DM have been identified but neither
accurately predicts cardiovascular complications. An emerging, novel early prediction method of CVD in T2DM
is epigenetics. Epigenetic changes are modifications to the genome that regulate gene transcription without
actually changing the underlying nucleotide sequence. Endothelial cells (ECs), which line the interior of blood
vessels, become dysfunctional in T2DM and are the first step in CVD progression. ECs maintain long-term
expression of pro-inflammatory genes even after normal glucose levels have been attained, suggesting
epigenetic changes might be responsible for enduring changes in gene expression that contribute to CVD. It is
unknown, however, the extent to which epigenetic changes mediate early cardiac endothelial cell dysfunction
in T2DM and whether these changes can be rescued with lifestyle interventions like exercise. The short-term
goal of this project is to determine the effect of hyperglycemia on epigenetic modifications (measured via
chromatin accessibility) in cardiac endothelial cells and how these are modified by an exercise intervention in a
translational mouse model. The long-term goal is to help develop early effective prediction, prevention, and
management of cardiovascular complications in patients with T2DM. I hypothesize hyperglycemia will cause
differential chromatin accessibility in inflammatory pathway genes that will be prevented by concurrent
aerobic exercise. I will test this hypothesis using two specific aims: 1. Determine the effect of hyperglycemia
and insulin resistance on epigenetic changes in cardiac endothelial cells. I will use a translational mouse
model, which is readily available in our lab, to implement a diet intervention and isolate cardiac endothelial
cells. 2. Test whether an aerobic exercise intervention prevents hyperglycemia-induced epigenetic changes in
cardiac endothelial cells. I will test four randomly assigned groups of mice: control diet (CD), CD + exercise,
high fat diet (HFD), HFD + exercise. This project is significant and innovative because it investigates a long-
standing cause of death in an extremely prevalent disease using a novel epigenetic analysis approach. This
project fits within the applicant’s long-term research goals of using translational science models to improve
understanding, prevention, and treatment of cardiovascular complications in patients with chronic metabolic
diseases. This research will establish the early effects of hyperglycemia and insulin resistance on
epigenetic changes in cardiac endothelial cells and whether they can be mitigated through exercise,
setting the groundwork for effective early identification and treatment of cardiovascular complications
in T2DM. The proposed study is aligned with three of the NINR Strategic Plan areas – health promotion and
disease prevention, advancing the quality of life, and innovation.

Public health relevance
PROJECT NARRATIVE The U.S. has a high rate of type 2 diabetes mellitus (T2DM) and T2DM patients are at severe risk for morbidity and mortality from cardiovascular diseases, even if they have achieved good glycemic control. It is critical to understand the basic science mechanisms governing cardiovascular disease development in T2DMs and to develop novel early identification and treatment methods to prevent disease, promote health, and improve quality of life of patients.